Fluorescence microscopy for proposed research in the parent grant

Fluorescence microscopy is required for the research in the newly funded grant R35GM118175. This application is to allow the purchase a fluorescence microscope. The need for fluorescence microscopy is clear from our previous research funded by two R01 applications folded in the R35 award mechanism. More than half of the project description for R35GM118175 involves the analysis of mouse and cell mutants for proficiency in recombination: meiotic recombination, mitotic recombination (somatic cells), and replication fork protection, and live cell imaging will add a new dynamic.

Public health relevance
Lesions that arise in the genome compromise its integrity and so must be repaired, since lack of repair or misrepair leads to genomic loss or rearrangements, which are associated with many tumor types, including breast and ovarian cancer. Conversely, some lesions are beneficial because their repair leads to proper gamete formation by promoting the segregation of maternal and paternal chromosomes, errors of which can lead to developmental issues. This project addresses fundamental questions about the repair of DNA lesions in which both strands of DNA are broken, and impacts our human fertility, development, and cancer.